Transcranial Stimulation in Spino-Cerebellar Ataxia

DESCRIPTION (provided by applicant): Spinocerebellar ataxia (SCA) refers to a family of genetic diseases that cause progressive problems with gait and balance, as well as other debilitating symptoms. Even though the genes responsible for many of the SCA subtypes are known, and even though we know that they all are associated with damage of the cerebellum and other specific parts of the brain, there is no cure for SCA and we still lack an effective symptomatic treatment. We propose a novel approach using noninvasive transcranial magnetic stimulation (TMS) to improve balance, gait, and posture in patients with SCA. We will recruit 20 patients with genetically-confirmed SCA. Half will be randomly assigned to a real intervention, and half to a sham (i.e., control) intervention. The TMS intervention will consist of 20 stimulatio sessions over a four week period. At baseline and at follow-up, all patients will undergo comprehensive assessments including several SCA rating scales, along with sophisticated tests of balance (i.e., walking, standing and muscle coordination). Patients will also complete a series of neurophysiologic tests to evaluate the function of the cerebellum and its connections before and after the intervention. This will help us test the clinical utility of the intervention and als gain new knowledge about the basis for the disability in SCA. In pilot studies we have shown already that TMS is safe when applied to the cerebellum and that it can improve balance in patients. We now will conduct a more systematic, larger, carefully controlled proof- of-principle clinical trial We anticipate that patients receiving real rTMS will show better balance, fewer falls, and improved mobility while those undergoing sham stimulation will show no benefits. If our prediction is correct, this study will provide evidence-based support for a new treatment to improve the lives of patients with SCA, and the proposed quantitative evaluations will examine possible objective end-points for a future, larger multi-site clinical trial.

Public health relevance
PUBLIC HEALTH RELEVANCE: Spinocerebellar ataxia (SCA) refers to a family of genetic diseases that damage the cerebellum and other brain regions, and cause progressive problems with gait and balance. We propose a randomized controlled pilot study to test a novel therapeutic intervention that uses noninvasive magnetic brain stimulation to improve functional outcomes in patients with SCA. The study will include quantitative evaluations of gait, balance and brain physiology to examine possible objective end-points for a future, larger multi-site clinical trials. We anticipate that patients receiving the real intervention will show a functional gain. If our prediction is correct, this study will provide evidence-based support for a new treatment to improve the lives of these vulnerable individuals. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The autosomal dominant spinocerebellar ataxias (SCAs) are a complex group of neurodegenerative disorders associated with degeneration of the cerebellum and its efferent or afferent tracts, including the pontomedullary system, spinal tracts and peripheral nerves. Despite the advances in identification of the underlying genetic causes for the various SCA subtypes, we currently lack effective, curative therapies, and SCA leads to progressive functional decline and disability. Symptomatic treatment of SCAs remains limited and patients manifest a host of progressively debilitating balance disturbances along with other debilitating symptoms. Falls are a major cause of morbidity in patients with SCA, with over 90% of patients with SCA experiencing at least one fall each year. Falls are most commonly caused by movement disturbances related to axial and appendicular ataxia, gait instability and spasticity. Dysfunction in the cerebellum and its connected neural networks is thought to be the proximal root cause of symptoms and disability in SCA. Therefore, we predict that successful improvement in function of the cerebellum and its connected neural networks would lead to significant clinical benefit, reduce disability and morbidity, and improve the quality of life of patients with SCAs. Repetitive transcranial magnetic stimulation (rTMS) enables noninvasive, selective and sustained modulation of specific neural networks, and can lead to clinical benefits in debilitating neurologic and psychiatric disorders, including medication-resistant depression, paresis following stroke or traumatic brain injury, Parkinson's disease or dementia. TMS uses electromagnetic induction to generate controlled currents in specific brain structures that can be identified and defined using MRI-based neuronavigation. TMS is safe if appropriate guidelines are adhered to. To date, the impact of rTMS on SCA has not been sufficiently established, but pilot studies offer promising results. We propose to investigate the therapeutic efficacy of rTMS in patients with genetically-identified SCA by conducting an MRI-guided neuronavigated, double-blind, proof-of-principle, sham-controlled rTMS clinical trial along with extensive functional and neurophysiological assessments before and after the rTMS to systematically quantify the mechanistic underpinnings of rTMS-induced improvements. We hypothesize that: Hypothesis 1: As compared to the sham intervention, SCA patients receiving the real rTMS intervention will demonstrate greater improvement in functional outcomes. Hypothesis 2: A) At baseline, SCA patients with greater cerebello-cortical connectivity will have better functional outcomes; B) Improvements in functional outcomes related to the real rTMS intervention will be associated with increased cerebello-cortical connectivity. The rTMS intervention will consist of 20 sessions over a four-week period. Baseline and follow-up functional tests will include widely-employed and well-validated SCA rating scales, along with sophisticated biomechanical assessments of gait, standing postural control, muscle coordination and turning. This state- of-the-art biomechanical assessment of human movement and muscle activation will quantify specific rTMS-related changes in the motor control gait, posture, and turning ability, and ultimately provide sensitive, objective metrics that might be used as surrogate outcomes in future trials. Careful neurophysiologic investigation before and after the rTMS intervention will serve to explore the association between functional outcomes and metrics of cerebello-cortical connectivity and corticospinal integrity in patients with SCA. The proposed study is therefore significant because it will produce strong, first-of-its-kind proof-of- principle evidence on whether rTMS can provide meaningful symptomatic relief to patients with SCA. Moreover, it will inform a more definitive, larger-scale randomized controlled trial by providing information on recruitment and retention, compliance and estimates of effect size, as well as the neurophysiological and biomechanical underpinnings of expected functional improvements.